The HOP-STEP Intervention: Improving Maternal Health in Women with Lupus through Improved Pregnancy Prevention and Planning

ABSTRACT:
Despite published guidelines, pregnancy prevention and planning for women with systemic lupus erythematosus
(SLE) is often sub-standard, leading to life-long morbidity for women and their offspring. SLE is a multi-system
autoimmune disease that primarily affects young women, and most severely, women of color, who suffer higher
rates of renal failure, death, and severe pregnancy complications. Unplanned pregnancies are particularly risky
with rates of pregnancy loss and preterm birth more than doubled due to active SLE and treatment divergent
from the American College of Rheumatology Reproductive Health Guidelines. Effective pregnancy prevention &
planning is essential to avoid tragic pregnancy complications, but gaps in current rheumatology care prevent
women with SLE from receiving the accurate and personalized guidance they need to plan a safe pregnancy.
The long-term goal is to enable all women with SLE to maintain a healthy pregnancy while enjoying a high level
of mental and physical health as they build the families they want. To fill the existing gap in provider knowledge,
skills, and practice, we created the simple in-clinic Healthy Outcomes in Pregnancy with SLE Through Education
of Providers (HOP-STEP) intervention. This innovative intervention creates routine opportunities for guideline-
aligned reproductive health care by 1.) restructuring the rheumatology clinic environment to collect patient-re-
ported contraceptive use and pregnancy intention, then 2.) enabling accurate and personalized care with a Dis-
cussion Guide, and 3.) providing informative hand-offs to collaborating physicians. In doing so, the intervention
insures equitable, patient-centered reproductive care is provided to all women with SLE. The working hypothesis
is that equipping rheumatology providers with this intervention will increase the frequency that women with SLE
receive effective pregnancy prevention and planning care, which will result in more planned pregnancies and
decrease tragic outcomes for both mother and baby. The objective of this grant is to prepare for a multi-center
trial of the HOP-STEP intervention by fitting and then piloting its implementation and measuring its potential
impact on maternal outcomes. Because of existing disparities in current SLE care and pregnancy outcomes, the
intervention will be piloted within a predominantly Black and low-income population. Evidence-based implemen-
tation strategies for the multi-center trial will be selected based on the impact each strategy has on the equity of
reach, effectiveness, adoption, and fidelity. This pilot trial will be accompanied by analyses of pregnancy timing
on maternal health among women with SLE, first in existing data from over 100 pregnancies, then in pregnancies
that occur in the pilot intervention trial. The project will be guided by two national Community Collaborator teams,
one comprised of women living with SLE and the other with rheumatologists, OB/GYN, and primary care provid-
ers. At the completion of this study, we will be prepared for a multi-center trial of the intervention that focuses on
equitable improvements in care, maternal health, and pregnancy outcomes. This study is the next, essential step
to allow women with SLE to effectively plan their pregnancies, leading to healthier women, babies, and families.

Public health relevance
Project Narrative: This proposal directly addresses the IMPROVE Initiative by testing an intervention to reduce preventable causes of maternal morbidity among people with SLE. SLE doubles the risk for severe maternal morbidity with risks escalating further with frequent co-morbid conditions; gaps in pre-pregnancy care within the rheumatology clinic further these risks, resulting in lasting damage to women with SLE and their infants. This innovative, in-clinic intervention will enable rheumatologists to provide equitable, accurate, and personalized pregnancy prevention and planning recommendations to women with SLE, empowering women to plan the pregnancies they want.